Rise of lasR mutant Pseudomonas aeruginosa keratitis

Project Summary / Abstract
The NIH funded Steroids for Corneal Ulcers Study found that keratitis caused by naturally occurring lasR
mutants of the bacteria Pseudomonas aeruginosa resulted in significantly worse vision outcomes than keratitis
caused by wild-type P. aeruginosa. All the isolates, from India, were obtainted between 2006-2010. Using the
vast repository at the University of Pittsburgh Campbell Laboratory, which has isolates back to 1992, a
concerning trend was observed that lasR mutants have dramatically increased among P. aeruginosa keratitis
isolates in the United States. This is a potential public health problem that this study would help to
communicate to ophthalmologists and optometrists. The long-term goal of this research is to develop
approaches to prevent vision loss caused by infections. The overall objective of this application is to determine
the mechanism by which lasR mutants of P. aeruginosa cause worse clinical outcomes. Our central hypothesis
is that the LasR transcription factor inhibits expression of genes that influence P. aeruginosa survival on the
harsh ocular surface, such that genes upregulated in the mutant confer an increased infectivity phenotype. The
rationale for this study is that identifying the mechanisms by which LasR controls ocular virulence will provide a
scientific basis to develop therapeutic strategies to combat vision loss. Three specific aims have been
designed to interrogate our central hypothesis: 1) to characterize the genetic basis of lasR mutations among
the clinical isolate collection at the Campbell Laboratory, and evaluate the extent to which the mutations confer
dominant or recessive virulence phenotypes; 2) to test the importance of specific P. aeruginosa genes that
have increased expression in lasR mutants for a role in ocular surface survival, establishing corneal infection in
a rabbit contact lens infection model, and in inducing corneal inflammation, and 3) to test whether lasR mutants
have elevated resistance to ocular surface innate defenses and ophthalmically relevant antibiotic therapy. This
study will use a combination of advanced molecular genetics to manipulate bacterial genomes including clinical
isolates, next generation sequencing, and well-established in vitro and in vivo models. This study is innovative
because current diagnostic approaches do not differentiate between P. aeruginosa strains that cause keratitis,
other than antibiotic susceptibility, and this study will introduce a new approach to identify highly vision
threatening P. aeruginosa isolates. This study will also evaluate several candidate virulence factors that have
not been tested with respect to the eye. The significance of this study is based on two items: A) its high
potential to elucidate new pathogenic mechanisms that bacteria wield to establish blinding ocular infections,
and the resulting knowledge can ultimately be used to develop approaches to prevent vision loss due to ocular
infections, and B) introducing a feasible form of personalized medicine that can be used to alert health care
workers to patients most at risk for vision loss.

Public health relevance
Project Narrative Bacterial infections of the cornea are a major cause of vision loss and are relevant to the NIH's and NEI's mission. We have recently determined that over the last 25 years a more vision threatening mutant form of bacteria is rapidly increasing in frequency. Our project will determine why these mutants are more virulent, and will raise awareness of this problem, which will aid in public health and will find information that can help prevent vision loss due to infections of the eye.